Neurochemistry Component - Martin-Fardon

Abstract

A central problem in the treatment of ethanol (EtOH) addiction is the prevalence of relapse to EtOH use even
after protracted intervals of forced or self-­imposed abstinence. Advances have been made in elucidating the
neurocircuitry that mediates craving and EtOH seeking, which provides insights into the neurobiological basis
of relapse. Functional brain imaging in humans and studies that use c-­fos expression as a marker of neural
activation in rodents implicate interconnected cortical and limbic brain regions in response to drug cue-­, drug
priming-­, and stress-­induced reinstatement. Major components of this circuitry include the medial prefrontal
cortex (mPFC), basolateral amygdala (BLA), central nucleus of the amygdala (CeA), bed nucleus of the stria
terminalis (BNST), ventral tegmental area (VTA), nucleus accumbens (NAC), hippocampus, thalamus (THAL),
and dorsal striatum. The hypocretin (Hcrt) system regulates a wide range of physiological processes, including
feeding, energy metabolism, arousal, and stress, and is recruited by drugs of abuse. Of interest for the present
proposal, recent studies have demonstrated a critical contribution of Hcrt in the modulation of stress and a
possible anxiolytic effect of Hcrt receptor (Hcrt-­r) antagonists. Furthermore, we have collected convincing data
that EtOH exposure recruits the Hcrt system. Specifically, we found that downregulation of Hcrt mRNA was
observed in the lateral hypothalamus (the major source of Hcrt production) of animals that had a history of
EtOH dependence and that blockade of Hcrt-­r selectively reversed EtOH seeking vs. natural reward seeking.
Chronic drug use is well known to dysregulate stress responses that are mediated by corticotropin-­releasing
factor (CRF) in both the hypothalamic-­pituitary-­adrenal (HPA) axis and extrahypothalamic brain stress areas
outside the HPA axis (e.g., CeA and BNST). With repeated cycles of drug use, the HPA axis becomes
hyporesponsive, accompanied by an increase in the extrahypothalamic CRF stress system response (i.e.,
CRF-­CRF1 receptors). Importantly, a Hcrt/CRF interaction exists, and it has been proposed that Hcrt
modulation of CRF neurons participates in the chronic relapsing, negative affective states that characterize
drug addiction. Converging lines of evidence from human and animal studies suggest that impairment of mPFC
function due to drugs of abuse exposure is a key factor in the transition from goal-­directed to compulsive drug
seeking. The mPFC contains CRF interneurons, and Hcrt neurons project to the mPFC. This proposal will test
the hypothesis that a history of EtOH dependence dysregulates Hcrt and its interaction with CRF in the mPFC,
particularly the infralimbic area (IL), and if this dysfunction will predict compulsive EtOH seeking (relapse)
precipitated by stress during acute/early, late, and protracted abstinence that could explain compulsive EtOH
seeking. From the perspective of future medication development, this project is likely to highlight a previously
unrecognized mechanism in the etiology of compulsive EtOH seeking during abstinence;; ultimately leading to
the identification of novel therapeutic targets for the prevention of EtOH relapse.